Innate cellular responses against Adeno-associated virus in hematopoietic stem and progentitor cells influence cell survival and repopulation capacity

Gene editing of hematopoietic stem and progenitor cells (HSPCs) has the potential to cure many
genetic diseases of the blood and immune system. Using targeted nucleases followed by delivery of a DNA
donor template for homology directed repair (HDR) using an adeno-associated viral (AAV) vector, we and
others have achieved high efficiency gene correction at multiple therapeutically relevant genetic loci. Human
HSPCs can undergo high efficiency correction and reconstitute the blood and immune system in vivo after
engraftment into immune-compromised NSG mice. However, transduction by the AAV vector impairs cell
survival, proliferation, and engraftment efficiency. This proposal aims to understand the innate immune cellular
responses to the AAV vector at the bulk population and single-cell level in HSPCs in order to obtain high
efficiency gene correction without impairment of HSPC survival or self-renewal capacity.
Although HSPCs can undergo high efficiency HDR, these cells are drastically (4-10 fold) impaired for
engraftment compared to untreated controls, which we have determined is due to the AAV vector. In dose
response experiments, high copy number transduction demonstrated decreased cell viability and proliferation
as well as decreased progenitor cell survival as measured by Colony Forming Unit assay, toxicity which
correlates with increased nuclear accumulation of AAV genomes as measured by digital droplet PCR. We
therefore propose to investigate two antiviral pathways, NF-kB (Aim 1) and cGAS (Aim 2), across a range of
AAV copy numbers to determine their effect on HSPC survival by measuring activation of these pathways as
well as inhibition and knock-out experiments using transduction of GFP expressing vectors and CFU assays
for progenitor cell survival. After initial studies on progenitor cell survival we will determine whether transient
NF-kB and cGAS inhibition improves self-renewal of long-term hematopoietic stem cells through engraftment
in NSG mice. We will simultaneously use an unbiased hypothesis generating approach in Aim 3 to determine
cellular responses to AAV occurring in HSPC subpopulations through single-cell RNA-seq experiments which
may be missed in Aim 1 and 2 experiments using the whole population or large subpopulations.
My scientific environment and training plan are ideal for successful completion of this research
proposal. The Stanford Stem Cell Institute has many talented stem cell researchers which are highly
collaborative as demonstrated by our RNA-seq collaboration with Dr. Irv Weissman. The wealth of scientific
resources including our dedicated FACS core and career resources offered through the Office of Post-doctoral
Affairs, as well as scientific and career training from my mentor Dr. Porteus will allow me to achieve my
scientific and career goals. Successful completion of this proposal will both further our understanding of HSPC
biology and self-renewal in the context of antiviral responses, as well as improve the development of gene-
editing based therapeutics in HSPCs.

Public health relevance
Project Narrative Adeno-associated virus is a viral vector used for delivery of DNA templates for homologous-recombination based gene editing in hematopoietic stem and progenitor cells (HSPCs). Although this method can efficiently correct genetic defects in HSPCs to correct a variety of blood and immune disorders, toxicity observed from the viral vector appears to impair repopulation capacity of HSPCs after gene editing. This proposal will characterize innate cellular responses leading to impaired HSPC survival and repopulation capacity at the bulk population and single cell level, and determine mechanistic interventions that will improve engraftment of long- term hematopoietic stem cells in vivo.